Functional and structural organization of motor areas in non-human primates

PROJECT SUMMARY
We are requesting an administrative supplement to ensure that we can successfully complete the Aims of our
funded project 5R01NS105697. The objective of the project is to close knowledge gaps about structure-function
relationships in primary motor cortex of monkeys. At the conclusion of the project we expect to gain a better
understanding of how the brain controls voluntary movements of the body. Two unanticipated factors led to
financial challenges from the outset of the project. Our re-budgeting strategies allowed us to succeed in Years
1-3, but additional funds are now essential for successful completion of the project. The funds requested will
support animal costs and research supplies. These items are indispensable for meeting the original objectives
of the project.

Public health relevance
PROJECT NARRATIVE The present supplement is essential for successful completion of a funded R01 project. Funds would cover animal costs and supplies. The overall objective of the project is to close knowledge gaps about how the brain controls body movements, which is directly aligned with the mission of NINDS.